An actionable secretory program that drives tumor progression in a genetically defined subset of lung squamous carcinoma

Project Summary
Lung cancer is the primary cause of cancer-related death worldwide, with lung squamous cell carcinoma (LUSC)
being the second most common subtype. Although LUSC has been characterized by several well-defined driver
mutations, including amplifications of chromosomes 3q26, targeted therapy approaches have been unsuccessful
so far. Copy number gain or amplification of chromosome 3q occurs in more than 80% of LUSC, while progress
has been slow in developing therapeutic strategies to target this specific LUSC subtype. We have identified
several Golgi genes in this amplicon, including Golgi Integral Membrane Protein 4 (GOLIM4), which encodes a
transmembrane Golgi protein that regulates endosome-to-Golgi trafficking, and ATPase Secretory Pathway
Ca2+ Transporting 1 (ATP2C1), which encodes a Golgi-resident Ca2+/Mn2+ pump that regulates Ca2+-dependent
protein sorting and secretion. We found that GOLIM4 and ATP2C1 form a complex on the Golgi and play a
fundamental role in LUSC growth and metastasis by promoting the secretion of pro-tumorigenic proteins. In
addition, ATP2C1 regulates Mn2+ influx into the Golgi lumen, causing GOLIM4 degradation upon Mn2+ exposure.
Mn2+ treatment inhibits the growth of chromosome 3q-amplified LUSC cells in vitro and in vivo. In the proposed
work, we will explore how GOLIM4 and ATP2C1 cooperatively modulate the Golgi secretory pathway during
LUSC progression and test whether GOLIM4 and ATP2C1 co-amplification creates a therapeutic vulnerability in
chromosome 3q-amplified LUSC.

Public health relevance
PROJECT NARRATIVE Studies are warranted to elucidate the genetic and biochemical underpinnings of lung squamous cell carcinoma (LUSC), the second most common lung cancer type. Based on the preliminary results presented here, we postulate that chromosome 3q amplification reshapes the Golgi secretory pathway and creates a therapeutic vulnerability of LUSC. Our findings could have broad relevance given that chromosome 3q is frequently amplified in multiple cancer types.